Using Technology to Optimize Collaborative Care Management of Depression in Urban and Rural Cancer Centers

Project Summary/Abstract
The objective of this project is to improve the treatment of depression in cancer patients. Up to 25% of
people with cancer will become clinically depressed, significantly affecting their quality of life and functioning.
Depression has been associated with a decreased ability to tolerate and complete cancer treatment, as well as
significantly increased healthcare costs. Unfortunately, about 75% of cancer patients with depression do not
receive adequate treatment, and patients in rural settings are even less likely to receive adequate treatment.
Reasons for this large treatment gap include: (1) lack of standard processes for psychosocial follow-up and
treatment adjustments; (2) inadequate availability of mental health clinicians with experience in behavioral and
psychopharmacologic treatment of cancer patients; (3) patient inability to follow up with psychosocial treatment
due to medical illness, financial barriers, and transportation and other logistical barriers; and (4) ongoing stigma
and lack of engagement related to mental health care.
Collaborative Care Management (CoCM) is an evidence-based system of care that has been shown to
lead to sustained improvement in depression symptoms and quality of life in patients with cancer and other
medical conditions. CoCM is a population-based, integrated care approach, where care managers, who are
clinicians such as social workers, nurses or psychologists, deliver behavioral treatments, coordinate
psychosocial care, monitor outcomes, and adjust treatment with the input of a psychiatric consultant. Although
the CoCM model has been shown in a recent meta-analysis to be highly effective in the cancer setting,
high-fidelity implementation has been slow, particularly in low-resourced and rural areas. The use of
technology has the potential to enhance implementation and fidelity of CoCM in diverse cancer settings.
This proposed study will use a human-centered design approach to develop, build, and test a web and mobile
platform to enhance the implementation and fidelity of CoCM of depression for patients being treated at urban
and rural cancer centers. In Phase I of the study, patient-facing web and mobile applications and a clinician-facing
website will aim to: (1) enhance treatment engagement among patients and clinicians; (2) collect timely
patient-reported outcomes for measurement-based care; (3) promote patient-centered shared decision-making
for better treatment adjustments; and (4) maximize adherence to evidence-based guideline-level behavioral
and pharmacologic treatments. In Phase II of the study, the technology-enhanced CoCM system (t-CoCM) will
be compared to usual CoCM (u-CoCM) in a pragmatic Hybrid Type 1 effectiveness-implementation
randomized controlled trial to evaluate their ability to achieve optimal fidelity of CoCM and clinical outcomes.

Public health relevance
Project Narrative This research aims to contribute to the health of people with cancer by improving the treatment of depression in this population. The study will develop technology to optimize the delivery of an effective system of care for depression, called Collaborative Care Management. Improving the ability to effectively treat depression in people with cancer will reduce the disabling effects of cancer and its treatment and improve overall quality of life.